RECENT DEVELOPMENTS IN NON LINEAR MICROSCOPY

Interdiciplalnary Seminar~Lecture: September 25, 1996 Invited Lectures and Consultations: Prof. W. W. Webb 2 listings are occasionally listed per page, to save space.